Core: research support

The Research Support Core will be responsible for the coordination of all aspects of dispersing human and mouse tissues for the proposed program project and for coordinating use of the confocal facilities. The Research Core will be composed of the Core Director, James Melvin, D.D.S., PhD., Associate Director, Trevor Shuttleworth, Ph.D., and a Technical Associate, Ms. Linda Richardson. The Specific Aims of the core will be to: 1. Prepare all human parotid tissues and distribute these tissues to appropriate members of the Program Project. 2. Prepare and distribute all mouse parotid tissues to appropriate members of the Program Project. 3. Monitoring and maintaining the status of the different mouse knockout lines. 4. Coordinate the histological analysis of the human and mouse parotid tissues in collaboration with Dr. Art Hand at the University of Connecticut. 5. Ensure appropriate access to the two confocal microscope facilities for all members of the Program Project.